Development Core

DEVELOPMENT CORE
SUMMARY
The overarching goal of the Development Core is to transform the capacity of our Center for climate change and
health in two critical ways: First, the core is responsible for stimulating transdisciplinary, innovative, high impact
research on climate change and health that addresses the needs of vulnerable populations. Second, this core
is responsible for developing a diverse workforce prepared to advance research on climate change and health.
Towards those ends, the Core’s three aims are to: 1) Enact a pilot grant program that provides competitive
support for innovative transdisciplinary climate change and health research; 2) Foster and accelerate the
professional development of early career and junior investigators; and 3) Educate future leaders in climate
change and health. Under Aim 1, this Core will stimulate transdisciplinary research on health outcomes, potential
interventions and health equity pertaining to climate change and health relevant to our central theme through a
funding mechanism for pilot projects (“Urban Resilience Awards”); there will be five awards per year providing
up to $25,000 each year for transdisciplinary research pertinent to our central theme. Three of the awards will
be supported from the P20 grant; an additional two will be supported by the University of Cincinnati under the
same mechanism as a contribution to the development of this Center’s research capacity and productivity. Under
Aim 2, the Development Core will address the pressing public health challenges posed by climate change by
supporting the recruitment, mentoring, research, and training of the next generation of climate scientists. This
aim will involve working closely with the University’s recruitment initiatives for diverse students and faculty. In
addition, the Core will competitively fund one career development grant award per year for an early stage
investigator, and use multiple mechanisms for awards and internships for Graduate and Undergraduate
Scholars. Under Aim 3, this Core will work closely with the Graduate College to develop a Climate Change and
Health Certificate that brings together students from graduate programs as diverse as community planning,
sociology and social work, environmental and public health, epidemiology, medicine, communication, and
architecture and engineering. The educational aims of this Core are being given remarkable financial and
technical support by the UC Graduate College. In summary, this Core supports the overall mission of the Center
and introduces innovation by leveraging novel pilot grant mechanisms that catalyze interdisciplinary research
and collaboration. At the same time, this Core will spearhead several innovative educational initiatives to cultivate
the next generation of climate change leaders. Ultimately, our approach to bridging disciplinary boundaries will
empower a diverse workforce (students, scientists, clinicians, public health professionals, advocates) to effect
meaningful change and foster a resilient, health-conscious society in the face of evolving climatic conditions.